Optimizing a bio-behavioral intervention to promote viral suppression among HIV+ people who inject drugs on the U.S.-Mexico border

7. PROJECT SUMMARY/ABSTRACT
The primary goal of the proposed research is to build an optimized intervention to promote sustained viral
suppression among a group of Latinx people who inject drugs and who are living with HIV on the U.S.-Mexico
Border. We are using the multiphase optimization strategy (MOST). MOST is an engineering-inspired
framework for designing and building optimized interventions. The primary aim is to conduct a 2-to-4 factorial
design where participants are randomized to zero or up to four intervention conditions (each condition
comprises a different set of intervention components). The four components are receiving (or not receiving)
peer support services for medication-assisted treatment (MAT) uptake and persistence, behavioral activation
therapy for depression (BAT), Life-Steps medication adherence program, and patient navigation for HIV care.
The intervention is being implemented at Programa Compañeros, a community-based social service
organization in Cuidad, Juarez, Chihuahua, Mexico, a city nestled alongside El Paso, Texas. Participants will
complete a baseline survey assessment, complete their assigned intervention programs, and then return for 6-
,9-, and 12-month follow-up assessments. The primary outcome is sustained viral suppression defined as viral
load test results of <400 copies per mL on all 6-,9-, and 12-month follow-up visits. Results of Aim 1 will yield
estimates of the unique impact of each intervention component, as well as each combination of components,
on sustained viral suppression. The research team and partners will make decisions about what constitutes the
optimized intervention by judging the observed effect sizes and statistical significance against real-world
constraints that go into the delivery of this intervention. The secondary aims are to test theoretical mediators to
explain the influence of the intervention components on viral suppression outcome and moderators of this
relationship. We will first test the effect each component exerted at the first, 6-month, follow-up assessment,
followed by testing characteristics that may modify this relationship.

Public health relevance
8. PROJECT NARRATIVE This study proposes to promote sustained viral suppression by building an optimized intervention for people who inject drugs and are living with HIV on the U.S.-Mexico Border. Interventions have shown success in achieving shorter-term viral suppression outcomes among people who inject drugs, but we propose to identify the intervention components that derive the greatest benefits and impact on viral suppression with the goal to promote long-term viral suppression. The intervention is being implemented in a real-world setting and with real-world constraints in place to facilitate the greatest possibility of scalability.